Impact and Utilization of Scalable Functional Assays in Alagille Syndrome

PROJECT SUMMARY/ABSTRACT
Uncertainty in our understanding of the functional impact of variation in the human genome has grossly
impeded our ability to realize the full potential of now mature sequencing technologies. There is a universal
need in genomics for the development of tools to support high-throughput functional characterization of
genomic variants in disease genes. This proposal will develop Multiplexed Assays of Variant Effects (MAVEs)
to functionally assess genomic variation of over 10,000 variants in a ligand and receptor pair, JAGGED1
(JAG1) and NOTCH2, that result in the autosomal dominant disorder, Alagille syndrome, a pediatric cause of
liver, cardiac, vertebral, renal, ocular, and facial anomalies. Functional haploinsufficiency is the mechanism for
JAG1-related disease and the likely mechanism for NOTCH2-related disease, which is supported by the high-
frequency of protein-truncating and large gene deletions seen for JAG1-related disease and a by a high
intolerance for loss-of-function variants observed in population databases for NOTCH2. Missense variants,
which are identified in 15% of patients with a JAG1 variant and >50% of patients with a NOTCH2 variant, are
notoriously difficult to classify, but those that are pathogenic show defects related to protein misfolding,
intracellular retention, and an inability to heterodimerize. Moreover, a high incidence of missense variants of
uncertain consequence in both genes identified during routine panel testing for general cholestatic disease
confuses both patients and providers. Resolution of the functional consequence of all missense variation in
JAG1 and NOTCH2 through the development of high-throughput tools would greatly improve diagnostics and
reduce reporting of non-disease-associated variants.
We propose the development of MAVEs to simultaneously test the functional consequence of all disease-
relevant missense variants in JAG1 and a subset of those in NOTCH2. In Aim 1 we will design two separate
MAVEs to analyze membrane expression and NOTCH2-binding ability of all JAG1 nucleotide permutations as
readouts of protein function. In Aim 2 we will modify these MAVEs for use in studying all nucleotide
permutations across a region of interest in NOTCH2 that contains the JAG1-binding interface. In Aim 3 we will
test the fidelity of our assay system by studying variant effects in liver cell lines, including both a high-
throughput MAVEs approach and a low-throughput, but high-fidelity induced pluripotent stem cell (iPSC) model
approach. Aims 1 and 2 will include complementary structural modeling and binding assays while Aim 3 will
interrogate the role of cellular environment using disease-relevant cell lines, all of which we expect will validate
and extend our findings, providing insight into the biochemical and cellular consequences of pathogenic
variation. Ultimately, these data will resolve uncertainty in JAG1 missense variant function that will benefit
diagnostics, improve our understanding of the functional consequence for NOTCH2 variants, and provide
guidance for how to incorporate this functional data as useable evidence during clinical variant interpretation.

Public health relevance
PROJECT NARRATIVE A paucity in our understanding of the functional consequence of variation in the human genome is a major roadblock in the diagnosis and study of genetic disease. We will develop Multiplexed Assays of Variant Effects, MAVEs, to characterize the functional consequence of thousands of variants simultaneously in the disease genes JAGGED1 (JAG1) and NOTCH2, mutations in which cause Alagille syndrome, an autosomal dominant cause of pediatric liver, cardiac, vertebral, ocular, and renal disease. Scalable functional characterization using MAVEs will revolutionize the speed with which we are able to understand genomic findings, and we propose additional, complementary approaches to test assay through-put and employ high fidelity cell models to comprehensively interrogate the strength of functional assays for variant reclassification.